FY22 - APA BUILDINGS - BUILDING 1

This project will refurbish one of four existing APA Buildings (1026, 1033, 1034 or 1045). These buildings are currently vacant. The NCI is currently expanding the capabilities of the DCTD laboratories at the FNLCR and requires additional laboratory space to accommodate the new requirements. These buildings will require a full refurbishment